Translational Imaging and Behavioral Assessment (TIBA) Core

The Translational Imaging and Behavioral Assessment (TIBA) Core will provide state of the art infrastructure for preclinical translational imaging studies using optical and other modalities to study neural structure and activity as well as cognitive assessment in translational models for neurodevelopmental and neurodegenerative disorders. This core will be composed of a preclinical imaging center which bundles several small animal imaging modalities. These include Multiphoton Microscopy, 7T MRI and a new PET scanner, allowing multimodal imaging in animal models for the study of normative cognition and neurocognitive disorders. This approach will result in innovative and rigorous preclinical translational datasets that are more powerful than the individual standalone imaging modalities. A second component of Core C, in keeping with the theme of the CoNDA center of cognitive assessments, is the new rodent behavior core. This core will provide the center with the expertise, equipment, and space that is required to conduct innovative behavioral research. A wide array of cognitive and behavioral assessments would dove-tail with the in vivo imaging experiments in the preclinical imaging center.